ADMINISTRATIVE CORE

The Administrative Core has been led by the Center PI, Renee Jenkins, MD since the Center's inception in 2002 and is located at Howard University. She is assisted by a Research Administrator, Grants Analyst, and Administrative Assistant.